Clinical and Biomarker-Based Trajectories of Psychosis-Risk Populations in Kenya

ABSTRACT
The parent study, “Clinical and Biomarker-Based Trajectories of Psychosis-Risk Populations in Kenya”, aims to
build research capacity in Kenya, using state-of-the-art multimodal methods in order to map clinical outcomes in
adolescents and young adults at clinical high risk (CHR) for developing schizophrenia (Aim 1). This involves
building ERP/EEG infrastructure in Nairobi, by acquiring research grade acquisition equipment and software;
MRI upgrades, including advanced diffusion and fMRI BOLD imaging capability; and elaborate research training.
The study also collects multi-modal clinical and biomarkers over 24 months from 100 CHR participants including
brain MRI, ERP/EEG, genetics, and cortisol, as well as baseline data from 50 healthy volunteers (Aim 2). Finally,
the study would test the hypothesis that psychosis outcomes in Kenyan CHR populations will differ from the
international CHR cohort by having fewer psychosis conversions and improved functioning (Aim 3).
Our goal in this supplement request is to harmonize the research protocol and assessments with that of the 42
international sites within the ProNET and PRESCIENT networks, funded through the Accelerated Medicine
Partnership – Schizophrenia (AMP-SCZ) consortium. Components of this supplement will allow for: 1) increasing
the number of longitudinal timepoints to fifteen, 2) including healthy controls in longitudinal assessments, 3)
including passive and active digital biomarker assessment, 4) incorporating AMP-SCZ assessment training and
increased supervision, and 5) developing an ERP/EEG laboratory to enable high-quality data acquisition. The
study methods (with the exception of blood collection), protocol and recruitment criteria will mirror that of other
AMP-SCZ consortium sites, and data obtained will be publicly shared.
This supplement is important as there are no AMP-SCZ consortium sites within the continent of Africa. Our
publicly-shared results will facilitate cross-cultural investigations of CHR data, which is relevant considering the
rates of psychosis reported in those with African ancestry and ethnic heterogeneity of psychosis risk genes.

Public health relevance
PROJECT NARRATIVE Accurately identifying young people who would become psychotic is important for developing safe and effective preventive interventions. Recent international studies will investigate the various clinical outcomes and biological changes in those at clinical high risk for schizophrenia. Our study will ensure that similar research data is also collected from an African population, by mapping the trajectory of Kenyan adolescents and young people at high risk for schizophrenia. Results will provide insights into ethnic and cross-cultural influences on psychosis progression. By building capacity in clinical, MRI and EEG research in Kenya, we will facilitate sub-Saharan Africa joining future international research efforts.